Role of MIF-CD74 signaling as an immune regulator and therapy target in pancreas cancer.

Background and Innovation: Pancreatic ductal adenocarcinoma (PDA) is a lethal cancer with limited treatment
options. A major barrier to treating PDA is the immune suppression occurring within the tumor microenvironment
(TME), which allows tumor cells to evade targeting by the immune system and limits the efficacy of immune
checkpoint therapy (ICT). A key contributor to this immunosuppression are tumor-associated macrophages
(TAMs) present in the PDA TME. TAMs manifest a spectrum of activation states, ranging from inducing anti-
tumor responses to enhancing tumor progression. PDA tumor cells alter this spectrum by recruiting and
modulating TAMs to promote immune evasion. This results in a suppression of the anti-tumor T-cell responses
critical for effective ICT. Intriguingly, recent studies suggest that TAMs can be "reprogrammed" to activate the
immune system and enable adaptative immune responses to target cancer cells. In this context, we identified
the MIF-CD74 cytokine signaling axis as a novel regulator of tumor progression in PDA. Our preliminary data
indicate that tumor-derived MIF increases TAM recruitment, decreases T-cell infiltration into the TME, and
enhances tumor progression. While our data suggest a role for MIF in shaping the PDA TME, the function of MIF
and its receptor CD74 in regulating TAM activation, the impact on anti-tumor T-cell responses, and its potential
as an immunotherapy target in PDA remain unclear. In this proposal we will delineate how MIF signaling, through
CD74 on TAMs, promotes tumor progression by suppressing anti-tumor T-cell responses. In addition, we will
develop approaches to target this axis to reprogram TAMs and activate cytotoxic T-cell responses which could
enhance immunotherapy efficacy in PDA.
Innovation: This project will fill key gaps in our understanding of how MIF-CD74 signaling regulates tumor-
immune crosstalk in PDA and provide insights into its potential as a myeloid checkpoint target for immunotherapy
with implications that could extend to other cancer types. To this end, we develop novel models that provide
direct mechanistic insights into the role of MIF-CD74 signaling in PDA tumor cells (syngeneic MIF knockout tumor
lines), TAMs (MacΔCD74 mice), and human tissues (PDOTS). Furthermore, we employ single-cell RNA sequencing
techniques to generate novel datasets that will delineate the contribution of MIF-CD74 signaling to immune
heterogeneity present in the PDA TME. Finally, we leverage our findings to develop a novel immunotherapeutic
strategy that combines MIF-CD74 inhibitors with checkpoint blockade to overcome the limitations of ICT in PDA.
Significance and Impact to Veterans Healthcare: The risk of developing PDA is increased in military personal
due to the high prevalence of associated risk factors among veterans. In addition, veterans often present late in
disease progression where therapeutic options remain limited. This proposal will provide novel insights into the
immune regulation of PDA and uncover novel myeloid checkpoint targets for immunotherapy which could be
used to improve outcomes in veterans with pancreatic cancer.
Path to translation/Implementation: This proposal will provide the pre-clinical basis for investigating MIF
inhibition as a potential new immunotherapy approach in PDA. Building on our findings the next step will be to
incorporate MIF inhibitor therapy into existing clinical therapies for PDA patients. Monoclonal antibodies to
human MIF have been FDA approved for several diseases. In the future, we can assess these therapies in
combination with chemo- and immunotherapy backbones for PDA as part of a clinical trial.

Public health relevance
Pancreatic ductal adenocarcinoma (PDA) is one the most lethal cancers in the veteran population. The prevalence of PDA continues to increase in military personnel and is poised to become the second leading cause of cancer related death in the US. Despites its significance, current treatments have shown limited efficacy. By investigating the functions of MIF-CD74 signaling in regulating immune responses within the PDA tumor microenvironment, this project seeks to uncover mechanisms that contribute to immune evasion by tumor cells, which is a major contributor to therapy resistance and progression. This will enable development of strategies that could enhance the efficacy of immunotherapy in PDA and potentially for other cancer types where MIF- CD74 signaling is active. This has the potential to improve therapies and outcomes for veterans and military personnel afflicted with pancreatic cancer.